Group-based Prevention of Postpartum Depression: In-person vs. Virtual Delivery

PROJECT SUMMARY
Depression is one of the most common perinatal complications, with 1 in 7 mothers qualifying for a diagnosis of
postpartum depression (PPD). Sexual and gender minority (SGM) people experience PPD at comparable or
higher rates as cisgender, heterosexual people. Yet, extremely little is known about risk factors for PPD that are
specific to SGM people (e.g., minority stress) and there are no studies of PPD prevention or treatment among
SGM pregnant people. This project addresses these major gaps in knowledge that limit available, effective
services for preventing PPD among SGM pregnant people. It tests associations between minority stress, general
stress (i.e., cortisol), and PPD symptoms. It also examines, quantitatively and qualitatively, the benefit of a
universal (i.e., not SGM tailored) perinatal preventive intervention for PPD, delivered in English and Spanish, for
SGM pregnant people. The PPD prevention program, ROSE, is designed to increase access, scalability, and
address the mental health needs of underserved populations (e.g., racial and ethnic minority people). This
administrative supplement will leverage data collected in the parent R01, a randomized clinical trial that is testing
a virtual version against the in-person version of an evidence-based preventive intervention in a randomized
controlled trial (RCT). Data collected as part of this administrative supplement guided by minority stress and
LGBTQ health equity theories in every aim, will produce: (1) basic science on PPD among SGM and (2) a mixed-
methods evaluation of an efficacious PPD prevention program among SGM pregnant individuals. This project
will test the following aims: 1: Incorporate measures of stress relevant for sexual and gender minority individuals
across levels of analysis and examine associations of SGM-specific stress (i.e., minority stress) and general
stress (i.e., cortisol) with PPD symptoms. 2: Test if the hospital-based PPD prevention program is as effective
for SGM participants as for their cisgender, heterosexual counterparts, if the same hypothesized mediators
improve for SGM participants (e.g., social support), and examine if program effects are moderated by SGM
minority stress 3: Explore through rich qualitative data, program experiences, benefits (e.g., social support), and
unmet needs among SGM participants who completed the ROSE program, including across intersections of
minoritized SGM and racial/ethnic identities. This team, led by MPIs Davis and Rhoades, with support from Co-
I Perry, an expert in SGM health, will ensure this project’s success. The discoveries generated by this supplement
will narrow gaps in our understanding of how to effectively prevent PPD for SGM pregnant people.

Public health relevance
NARRATIVE Postpartum depression is a significant public health concern, as at least 1 in 7 individuals will experience postpartum depression, yet alarmingly little is known about rates of postpartum depression and efficacious treatment among sexual and gender minority people. This project has clear relevance, affecting this significant mental health problem by determining whether an established preventive intervention (group interpersonal psychotherapy) benefits sexual and gender minority people similar to their cisgender, heterosexual counterparts. Recommendations based on this study will support an improved understanding of and prevention efforts for postpartum depression for pregnant sexual and gender minority people.